Amplifying the Impact of the Fresh Fruit and Vegetable Program Beyond Schools: A Multisectoral Approach

Project Summary / Abstract:
USDA‘s Fresh Fruit and Vegetable Program (FFVP) targets low-income schools, providing fresh fruit and
vegetable (FV) snacks to elementary school children. Evidence shows that students who participate in the
FFVP develop greater preferences for and consume more FV. Students also request more FV at home and at
the store compared to their peers who attend non-participating schools, influencing parent/caregiver purchases
and benefiting other members of the household. Promoting FFVP items in stores can capitalize on these
healthy requests, prompting parents to act on them and purchase more FV. We have documented the
eagerness of grocery stores, FFVP schools, and USDA’s Supplemental Nutrition Assistance Program-
Education (SNAP-Ed) to form partnerships to promote FFVP items in stores. While FFVP’s current operations,
confined to school settings and primarily focused on the student, limit its ability to have broader impacts, the
program’s success demonstrates its potential to serve as a foundation for broader, multisectoral initiatives. By
integrating efforts across education, public health, and food retail sectors, we can leverage the FFVP to reduce
health disparities in FV consumption. To test this multisectoral approach, we propose to develop and test a
novel Public-Private Partnership (PPP) consisting of three sectors -- Arizona’s FFVP, Bashas’ Food City stores
(a regional grocery store chain), and SNAP-Ed. The PPP will coordinate efforts of the schools offering FV
snacks through FFVP while also promoting these items in grocery stores. We hypothesize that our
multisectoral approach can expand and amplify positive health impacts on underserved students and their
families beyond what can be achieved in school settings alone. We will test the PPP in a cluster-randomized
trial, randomly assigning 16 schools selected for FFVP by the Arizona Department of Education (ADE) to
FFVP+ (intervention, 8 schools) or FFVP-only (active control, 8 schools) conditions, with a third observational
non-FFVP (passive control group) group sampled randomly from similar schools that were not selected for
FFVP (8 schools). Conducted across two phases, we will first test the feasibility of implementing a PPP and
then use a confirmatory cluster-randomized trial design to evaluate the effectiveness of the intervention on
students and their caregivers’ consumption as well as establish the sustainability of the PPP by estimating the
cost-benefit to grocery stores. Evidence of the effectiveness of a PPP could support a scalable model for
amplifying the positive impact of the FFVP program on schools, families, communities and grocery stores.

Public health relevance
Project Narrative Every day, children from low-income and minority families face a higher risk of developing chronic diseases due in part to inadequate fruit and vegetable (FV) consumption; and while some single-sector interventions work to boost FV consumption in school settings, multisectoral approaches are needed to amplify the impact of FV programs to make population level impacts. Using a confirmatory cluster-randomized controlled trial, this study will test a novel intervention -- a Public-Private Partnership (PPP) between a successful school-based FV program, the Fresh Fruit and Vegetable Program (FFVP), and neighborhood grocery stores -- to amplify the benefits of the FFVP and expand its reach beyond the school setting. Results from our study will integrate into and augment the Multi-Sectoral Preventive Interventions (MSPI) Research Network, adding an innovative and effective PPP that addresses social determinants of health in children and their communities who experience health disparities due to low FV consumption.